Lysosomal Regulation and Functions for TBK1 in Neurodegenerative Diseases

Abstract
Lysosomes degrade and recycle macromolecules, clearing harmful materials and providing
nutrients, while also communicating nutrient availability to the cell. Although these functions are
critical in all tissues, the aging central nervous system is particularly sensitive to lysosome
disruptions. This sensitivity is evident in the wide range of neurodegenerative diseases caused
by mutations in genes encoding lysosomal proteins. A significant challenge in developing new
therapies from these genetic insights is the limited understanding of the fundamental cellular
processes affected by disease genes and the consequences of perturbing these processes in
specialized types of brain cells.
Identifying pathways where disease-causing genes converge is thus crucial for developing
therapies that target the cellular vulnerabilities underlying disease susceptibility and progression.
Our research focuses on TANK-binding kinase 1 (TBK1) and C9orf72, two genes whose
mutations cause amyotrophic lateral sclerosis and frontotemporal dementia (ALS-FTD). We have
identified a novel pathway where TBK1 signals at the lysosome surface. Additionally, we
have found that C9orf72 regulates this lysosomal pool of TBK1 and identified other activators of
TBK1 at lysosomes, including nutrients, lysosome damage, and innate immunity signaling.
We aim to elucidate the molecular mechanisms that integrate these signals to activate TBK1 at
lysosomes. We also seek to understand the contributions of this signaling to lysosome functions
in neurons and glia and to identify the targets of TBK1 kinase activity that mediate its effects on
lysosomes. To address these issues, we will use genome-edited cell lines to establish the
molecular mechanisms by which TBK1 coordinate lysosome function with cellular demand. These
mechanistic studies will be complemented with experiments in genome-edited human induced
pluripotent stem cells (iPSCs) and neurons and glia derived from them. This research will define
a new pathway in which TBK1 helps match lysosome function to cellular demand,
potentially revealing novel mechanisms for controlling lysosome function in ALS-FTD.
Given the broader role of endolysosomal pathway dysfunction across multiple neurodegenerative
diseases, our findings are likely to be relevant beyond diseases directly caused by mutations in
C9orf72 and TBK1.

Public health relevance
Aging and neurodegenerative diseases are linked to lysosome dysfunction, but effective therapies are hindered by insufficient knowledge of the regulatory mechanisms controlling lysosome activity in the central nervous system. Our research aims to identify these mechanisms through a focus on the mechanisms that control the ability of TANK-binding kinase 1 (TBK1) to signal from lysosomes. This research is expected to yield new insights into how TBK1 mutations and lysosome dysfunction contribute to dementias associated with the aging process.